Biological mechanisms underlying the relationships between environmental exposures and risk of respiratory and cardiovascular diseases

Published:
J Am Heart Assoc. 2024 Nov 19;13(22):e036984. doi: 10.1161/JAHA.124.036984. Epub 2024 Nov 7.
Associations Between Mosaic Loss of Sex Chromosomes and Incident Hospitalization for Atrial Fibrillation in the United Kingdom
Jungeun Lim, Aubrey K Hubbard, Batel Blechter, Jianxin Shi, Weiyin Zhou, Erikka Loftfield, Mitchell J Machiela, Jason Y Y Wong.
PMID: 39508149 PMCID: PMC11681411 DOI: 10.1161/JAHA.124.036984

Pre-print accepted by journal:
medRxiv. 2025 Jan 12:2025.01.10.25320341. doi: 10.1101/2025.01.10.25320341.
Personal care product use and risk of adult-onset asthma: findings from the Sister Study
Jungeun Lim, Che-Jung Chang, Alexandra J White, Shelton Lo, Hantao Wang, Gabriel Goodney, Rui Miao, Amisha V Barochia, Véronique L Roger, Dale P Sandler, Jason Y Y Wong
PMID: 39830231 PMCID: PMC11741502 DOI: 10.1101/2025.01.10.25320341

Pre-print:
Residential Ozone and Risk of Chronic Obstructive Pulmonary Disease in the United States: Demographic Differences in the All of Us Research Program
Shelton Lo, Gabriel A Goodney, Hantao Wang, Jungeun Lim, Susan Valerie Czach, Jared A Fisher, Joseph J Shearer, Maryam Hashemian, Véronique L Roger, Rena R Jones, Jason YY Wong.
PMCID: PMC12132121 PMID: 40463549